Advancing Equity in Cancer Care: Investigating Health- Related Social Needs and Colonoscopy Follow-Up Among FQHC Patients

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) is the second leading cause of cancer-related deaths among both men and women in
the US, with screening recommended by the US Preventive Services Task Force (USPSTF) to reduce
incidence and mortality. Despite national targets, CRC screening rates, especially among patients receiving
services in low-resourced settings, remain below these goals. Federally Qualified Health Centers (FQHCs)
serving predominantly underserved populations face challenges in achieving equitable screening rates. Health-
related social needs (HRSNs), such as housing instability and transportation issues, play a significant role in
CRC screening completion disparities. However, their impact on patients' CRC screening completion remains
underexplored.
This diversity supplement (DS) proposal will investigate the associations between HRSNs and follow-up
colonoscopy receipt among FQHC patients with abnormal stool-based test results. This population will be
reached by leveraging outreach to safety-net settings such as The Ohio State University Wexner Medical
Center, KPNC/KPSC and the American Academy of Family Physicians National Research Network
partnership—all strategies for aim 3 of the parent grant. This DS complements the proposed work in the parent
grant, primarily through its support of its first specific aim. For parent grant Aim 1, the DS will contribute a
qualitative approach to understanding the CRC screening continuum through the lens of a particularly
disadvantaged population (FQHC patients), paying special attention to patients' HRSNs. The DS will further
contribute to the understanding of recommendation-concordant CRC treatment timeline adherence for
members of this population who receive abnormal stool test results. The results of the DS will provide
covariates of interest (e.g., specific HRSNs, Social determinants of health) for the statistical analyses proposed
in Aims 2 and 4 of the parent grant. Data will be collected that may ultimately influence the development of
interventions targeting HRSNs to enhance CRC screening completion rates in vulnerable populations. Drawing
from existing literature on other cancer types, we hypothesize that patient-level HRSNs strongly influence
screening completion and subsequent outcomes.
Dr. Aldenise Ewing, the DS candidate, aspires to become an independent investigator focusing on addressing
cancer-related health disparities. This supplemental application will provide a mentored experience in cancer
health disparities and cancer control for Dr. Aldenise Ewing. The study findings will provide preliminary data on
social determinants of CRC-related outcomes and strengthen her K01 submission within 2 years of funding
and R01 or equivalent grant submission within 5 years of funding. Moreover, it will contribute crucial insights
into addressing social determinants of health in low-resource settings, ultimately improving health outcomes for
all populations.

Public health relevance
PROJECT NARRATIVE The primary objective of this application is to promote researchers with diverse backgrounds, like Dr. Ewing, in the field of cancer health disparities and cancer control. The purpose of this study is to investigate the impact of health-related social needs on follow-up colonoscopy receipt among patients with abnormal stool-based test results. The results from this study will inform interventions that improve colorectal cancer screening completion rates in low-resourced settings.